RENAL, NEUROLOGICC, AND REPRODUCTIVE EFFECTS--ENVIRONMENTAL LEAD EXPOSURE

The objective of this project is to study the effects of lead (Pb) on renal function. This project will evaluate the utility of several clinical and subclinical indicators of renal function among persons with chronic exposure to lead.